Antibiotic Resistance Determination Utilizing Machine Learning

Summary
Our long-term objective is to tackle antibiotic resistance by developing accurate and interpretable prediction
machine learning models that could be used clinically to speed up the care of patients with bacterial infections.
Current approaches to diagnosing bacterial infections rely on first culturing a pathogen from a collected specimen
followed by a variety of phenotypic tests to determine what antibiotic a particular bacterial isolate would be
sensitive or resistant to. This process can, in many cases, take days to finish. Developing an accurate way to
predict antibiotic resistance utilizing whole-genome sequencing data without the need for phenotypic testing is
the overall goal of this project. Our team applies the latest advances in deep learning and cloud computation.
We will pursue the following Specific Aims: 1) Curate a large dataset and develop a deep-learning prediction
model with state-of-the-art accuracies for a wide range of bacterial species and antibiotic combinations; 2)
Develop personalized machine learning models for chronic infections; 3) create open-sourced scalable user-
friendly resources for the broad research community. The successful completion of this work will provide a
paradigm shift in the way we diagnose bacterial infections and speed up the time to providing the correct
antibiotic for a specific pathogen.

Public health relevance
Narrative Antibiotic resistance (AR) is a substantial threat to public health. By utilizing advances in sequencing technology and machine learning, we propose novel deep learning models to 1) predict AR for many combinations of bacteria and antibiotics; 2) provide personalized performance AR prediction models for chronic infections; 3) disseminate cloud-ready, scalable, and user-friendly online resource. This work can potentially lead to rapid, precise antibiotic prescriptions leading to effective treatments for infectious diseases and integrate the latest advances in data science for the AR research community.